Administrative Core

PROJECT SUMMARY (Administrative Core A)
The Administrative Core (Core A) will function as a resource to assist Project and Core leaders as well as all
project personnel with the administrative tasks associated with this Program Project Grant (PPG). The
Administrative Core will allow investigators to focus as much attention as possible on the scientific and research
activities proposed in this PPG. The core will ensure efficient and timely execution of scientific, budgetary, and
administrative requirements and deadlines associated with the PPG. The communication and coordination of
these activities by the core are essential to accomplishing the objectives and goals of the Program Project. As
Principal Investigator (PI) of the PPG and Leader of the Administrative Core, Dr. Augustine Choi will provide
guidance for the day-to-day administrative details, program coordination, and planning and evaluation of the
program. He will work closely with the Steering Committee to execute and manage the PPG. The Steering
Committee of the PPG will consist of the leaders and key members of the Projects and Cores at Weill Cornell
Medicine (WCM), Brigham and Women's Hospital (BWH), Harvard School of Public Health (HSPH), and Brown
University. An Internal Advisory Board and External Advisory Board will provide support, advice, and guidance
for the PPG. The Internal Advisory Board consists of a highly experienced team of advisors with collective
expertise to provide guidance to the PPG. An External Advisory Board will be assembled with members who are
thought leaders in IPF and COPD, with expertise in basic, translational and clinical research. The overall goal of
Core A is to provide administrative support for all investigators participating in this PPG, which will be achieved
by addressing the following specific aims.
Aim 1: we will provide administrative support for the coordination of regular scientific and review meetings.
Aim 2: we will provide administrative support for regulatory and scientific reporting of the research activities.
Aim 3: we will provide administrative support for budgetary and personnel resource management.
Aim 4: we will provide and coordinate all administrative activities between the participating PPG institutions:
Weill Cornell Medicine, Brigham and Women's Hospital, Harvard School of Public Health, and Brown University.